Collaborative Data Services Shared Resource

PROJECT SUMMARY: COLLABORATIVE DATA SERVICES SHARED RESOURCE
Collaborative Data Services Shared Resource (CDSSR) of the Fred Hutch/University of Washington/Seattle
Children’s Cancer Consortium provides strategic services in the design, oversight, and implementation of
scientific studies by Consortium faculty members. It supports multiple studies, through managing participant
recruitment and retention, capturing data, surveying study participants, and designing and managing
biospecimen repositories. CDSSR collaborates with researchers to implement funded research studies by
developing novel, tailored approaches to individual project needs either by adapting current services, or by
introducing new technologies or services CDSSR has 12 full- or part-time staff, and three service cores: (1)
Programming; (2) Project Management; and (3) Interviewing, Translation, and Interpretation Services (ITIS).
These operate under three managers with expertise in these areas, and an administrator. CDSSR is directed by
Dr. Catherine Duggan, with guidance from an eight-member faculty advisory committee, which meets twice
annually. CDSSR services support Consortium goals by providing access to (1) customized programming
services and data infrastructure solutions; (2) project management beginning with consultation with researchers
prior to study initiation, through project development, and implementation. These activities leverage in-house
research and administrative support services including IRB submissions, and tracking and reporting clinical
research activities in the Fred Hutch clinical trial management system (CTMS); (3) a research call center staffed
by a highly trained team of bilingual (Spanish/English) research interviewers; (4) Spanish-English medically-
certified translation and interpretation services; (5) training to Consortium faculty and staff on data capture,
programming, and interviewing techniques; and (6) infrastructure support to maintain programmatic functions—
for example, design of biospecimen repositories, call center management, and maintenance of the Consortium’s
instance of Research Electronic Data Capture (REDCap). For the period of FY19 through FY23, CDSSR
provided services to 100 Consortium member users, representing 71% of all users and all the Consortium’s
research programs. CDSSR supported publication of 145 peer-reviewed manuscripts; maintained training
support for REDCap users and research staff and research interviewing techniques; and increased cost-
effectiveness and efficiency of multiple studies. Priority is given to Consortium faculty with peer-reviewed projects
and junior faculty seeking peer-reviewed funding. The resource continues to expand upon its technical,
collaborative, and project management expertise, by providing access to current technologies adapted for
research use, introducing new services based on clients’ needs, and expanding its client base.